Environmental influences on Child Health Outcomes in the Northern Plains PASS-ECHO Cohort

PROJECT SUMMARY
This proposal serves to leverage the Safe Passage Study ECHO (PASS ECHO) research infrastructure that has recruited a
large cohort of ECHO mother/child pairs (n=6.647) for continued follow-up, as well as continued enrollment of new
pregnancies and initiating a preconception cohort. The success of the PASS ECHO research team from 2016-2023, both in
scientific collaboration and completing of operational tasks, provides an excellent foundation for increased enrollment
and retention of ECHO participants, including a large proportion of rural and American Indian participants. PASS ECHO
has a specialization in the ECHO Obesity health outcome. The following specific aims relate directly to advancing
collaborative ECHO Cohort science and completing operational tasks relevant for successful participation in the next phase
of ECHO. (SA1) Examine the effects of prenatal allostatic load, and its biomarkers, on childhood obesity and
neurodevelopment. (SA2) Examine the independent and joint effects of prenatal life-style related exposures on child
obesity-related outcomes, and how nutrition may impact these relationships. (SA3) Build upon demonstrated successful
strategies and strong community/participant relationships to implement the ECHO-wide protocol v3.0 with deliberate
efforts to increase participation in American Indian and rural communities.

Public health relevance
PROJECT NARRATIVE This proposal serves to expand knowledge on prenatal stress and life events and it’s later effect on child obesity and development, with particular emphasis on how nutrition impacts these relationships. PASS ECHO is based in South Dakota and brings geographical diversity to ECHO, including a large number of rural participants, as well as a significant number of American Indian participants. During Phase I, 6,647 mother child pairs were enrolled in PASS ECHO and we are proposing an additional 1,650 new prenatal recruits.